Specialized CCSG supplement SODH and Quality of Cancer Care in HIV-associated Cancers

PROJECT SUMMARY/ABSTRACT
Persons with HIV (PWH) experience worse cancer outcomes compared to those not living with HIV.
Numerous social and structural determinants of health (SDOH) have been identified for PWH, and for cancer
care, including cultural barriers, stigma, insurance status, healthcare access, the built environment, and more.
HIV stigma is associated with suboptimal engagement in care, differential cancer risk, and prevention behaviors.
Further, the cumulative burden of living with HIV compounded by a cancer diagnosis can negatively affect clinical
outcomes. Few studies have explored the perspectives of PWH and cancer, limiting development of interventions
designed to improve the treatment experience and outcomes. Additionally, PWH from the most marginalized
groups who are diagnosed with cancer have risk factors for poor health outcomes. Gender and sexual minorities
as well as people who are Black or Latinx tend to have less access to health care, poorer quality of care and
general health outcomes. However, little is known about how SDOH risk factors intersect and affect HIV cancer
outcomes.
We seek to improve understanding of SDOH including patient, provider, and system-level drivers of cancer
disparities among PWH to identify the most critical and actionable areas for intervention. Our specific aims are
to (1) Explore HIV care engagement, and the cancer prevention, diagnosis, and treatment experiences of
PWH diagnosed with cancer, focusing on (a) health care engagement and treatment adherence prior to
and after cancer diagnosis and (b) the roles of social stigmas (e.g., HIV stigma, cancer stigma, racism,
homophobia) in cancer screening and diagnosis; (2) Examine associations of SDOH with the cancer
diagnosis, treatment and outcomes among PWH receiving care or follow-up of cancer at UCSD. This will
be accomplished using a mixed methods approach including (1) Semi-structured qualitative interviews
conducted with consenting UCSD patients undergoing cancer care or monitoring to better understand the
experience of PWH receiving cancer care and (2) quantitative methods to identify SDOH factors associated with
health outcomes in UCSD’s cohort of PWH and cancer via EMR abstraction coupled with a short quantitative
survey. Identified factors will be associated with cancer outcomes including stage at diagnosis, engagement in
cancer therapy, remission, and survival rates.
Accomplishment of these aims will contribute to understanding the social and structural determinants of
cancer care outcomes among PWH and identify actionable areas for future interventions aimed at
mitigation and elimination of cancer disparities in PWH.

Public health relevance
PROJECT NARRATIVE Many social and societal factors have been identified which negatively impact the health of persons with HIV and cancer including cultural barriers, access to healthcare, stigma related to race, ethnicity, HIV status, gender or sexual identity, and more. However, little is known about how these factors intersect to affect health outcomes for persons with HIV and cancer. This project seeks to improve understanding of these social and societal factors - including patient, provider, and system-level drivers of cancer disparities among persons with HIV - in order to identify future interventions aimed at eliminating cancer disparities in persons with HIV.